Admin Core

The main goals of the Administrative Core are to provide overall leadership for the CCCR,
manage the financial aspects of the CCCR, provide communication and outreach to
musculoskeletal researchers and evaluate the success of our efforts. The Administrative Core
leadership, Jeffrey G. Jarvik, MD, MPH and Janna Friedly, MD, MPH, both have national and
international reputations as outstanding scientific leaders. They will focus on furthering the
overall goal of the Center, to develop and provide scientifically rigorous, state-of-the-art
methods and resources for conducting musculoskeletal clinical research, thereby expanding the
community of investigators performing high-quality musculoskeletal clinical research and thus
increasing the amount of available useful data for researchers, clinicians, patients and policy
makers. The Administrative Core supports the individual Cores (Methodologic and Resource) in
achieving their aims. It also sets as a high priority attracting new and established investigators
within and outside UW to join the musculoskeletal research community contributing to and
utilizing the CCCR Cores. The Administrative Core coordinates and integrates all the CCCRs
activities. Given the complexity of multiple cores, data sets, investigators and projects, strong
central coordination is critical to success. The Administrative Core administers financial aspects
of the CCCR including cost recovery for use of CCCR Core resources to increase the
sustainability of the CCCR. The Administrative Core works closely with the External Advisory
Committee (EAC) to evaluate the success of the CCCR’s activities and consider new directions
and goals. The CCCR organizes biannual EAC meetings to provide feedback and guidance.
Publications are an important metric for the CCCR, and the Administrative Core will oversee the
Publications Committee, following already established authorship guidelines. The Administrative
Core oversees efforts to communicate the available resources and progress of the CCCR to the
NIAMS research community. Finally, the Administrative Core oversees the Visiting Scientist
Program and coordinates this program.